Designing an Intervention to Increase Men's Linkage to Care and Prevention after HIV Self-Testing in Uganda

PROJECT SUMMARY/ABSTRACT
The success of HIV treatment and prevention in sub-Saharan Africa (SSA) is hindered by the gender disparity in
access to care. Men in SSA are less likely to undergo HIV testing and more likely to start antiretroviral treatment
(ART) at advanced disease stages compared to women, resulting in poorer clinical outcomes. HIV self-testing
(HIVST) is shown to be an innovating and empowering method to increase HIV testing coverage in men. In
particular, secondary distribution of HIV self-tests to men from their female partners has achieved high uptake in
men. However, men’s linkage to care after HIVST is not well evaluated. As clinic linkage is a crucial step to
accessing lifesaving ART and prevention including pre-exposure prophylaxis (PrEP) and voluntary medical male
circumcision (VMMC), the success of HIVST interventions in reducing HIV burden hinges on their ability to link
individuals to care. The goal of this K01 Award is to broaden the candidate’s expertise to conduct independent
research in global HIV prevention, with a focus on optimizing HIVST and linkage strategies. To complete this
research, the candidate will develop new competencies in 1) qualitative research and behavioral science, 2)
behavioral economics, and 3) implementation science. These skills build nicely on the candidate’s current
proficiencies in epidemiology, mathematical modeling, and cost-effectiveness analyses. This newly developed
skillset will enable the candidate to design, evaluate, and adapt locally relevant and scalable HIV interventions
to reduce HIV burden in SSA. The candidate has assembled a robust, multidisciplinary mentorship team to guide
her research and career development. The research will be conducted in Kampala, Uganda, within a Prevention
of Mother to Child Transmission (PMTCT) clinic. This is an ideal setting in which to evaluate the effectiveness of
secondary distribution of HIV self-tests. Pregnant women commonly report not knowing the HIV-status of their
male partner. Furthermore, testing partners of HIV-positive women is a high yield strategy to identify HIV-positive
men in need of ART as well as HIV-negative men serodiscordant partnerships who can benefit from PrEP and
VMMC. Interviews will be conducted with men regarding their barriers and motivators for linkage and with
providers/stakeholders regarding the feasibility of integrating the potential interventions into clinic practice (Aim
1). Using the intervention characteristics identified in Aim 1, the candidate will create and administer a Discrete
Choice Experiment (DCE) to men with HIV-positive female partners (Aim 2). The DCE elicit characteristics of
men’s preferred HIVST intervention, which will be used to develop a tailored intervention for optimal uptake.
Finally, the candidate will pilot-test the optimal HIV-self testing intervention to 50 pregnant women starting
PMTCT and their male partners. She will evaluate the intervention’s acceptability and effectiveness in linking
men to confirmatory HIV testing, treatment and prevention (Aim 3). This research is the first to evaluate an
intervention to motivate male linkage to care after HIV self-testing. It has the potential to identify strategies to
increase HIV testing and linkage to care in SSA.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) Men in sub-Saharan Africa (SSA) are less likely than women to test for HIV and link to treatment and prevention, resulting in poorer clinical outcomes. Innovate HIV self-testing strategies demonstrate high male uptake and have the potential to increase HIV testing coverage, but methods to link men to care after HIV self-testing are not well evaluated. This research will study men’s barriers and motivators to clinic linkage after HIV self-testing and pilot-test a feasible and scalable intervention to increase linkage to care; this intervention will be designed and tailored for use in prevention of mother to child transmission (PMTCT) clinics in SSA.